Substrate Channeling and Communication in Proline Metabolic Enzymes

SUMMARY
(from the funded grant application)
Metabolic enzymes in cells rarely function in isolation, Often their activities are coordinated by physical or
covalent association with each other and cellular structures, A consequence of these associations is that
metabolic intermediates do not equilibrate with the cellular milieu and are instead channeled between
enzyme active sites, Despite the widespread recognition that protein-protein interactions are ubiquitous,
the molecular mechanisms of substrate channeling remain obscure, and the impact of channeling at the
cellular and organismal levels is largely unknown, We seek to narrow these knowledge gaps by exploring
substrate channeling within and between the enzymes of praline catabolism, The proposed experiments
will explore long-distance, allosteric communication between the active sites of the bifunctional enzyme
PutA using kinetic crystallography, assess the contributions of substrate channeling to bacterial fitness and
pathogenesis, and determine the first structure of a novel bifunctional enzyme that moonlights as a
transcriptional repressor using cryo-EM.

Public health relevance
NARRATIVE (from the funded grant application) This project explores the structural-molecular basis of communication between enzymes catalyzing consecutive chemical reactions in praline metabolism, These enzymes are increasing recognized for their roles in cancer and the virulence of pathogens, and mutations in praline metabolic genes cause numerous hereditary diseases, Understanding how the activities of praline metabolic enzymes are coordinated enriches our understanding of complex enzyme mechanisms and the multifaceted roles of praline metabolism in human health and disease.